Versatile platform for genome-wide R-loop mapping for aging and neurodegenerative disease research

PROJECT SUMMARY
R-loops are triple-stranded nucleic acid structures consisting of a DNA:RNA hybrid and a displaced single
DNA strand. R-loops are generally transient in nature, but persistence of stable R-loops leads to DNA damage
and genome instability, and dysregulation of these structures is strongly associated with aging and
neurodegenerative diseases. As such, the study of R-loops is essential to understand mechanisms driving these
diseases, and for the development of novel biomarkers and therapeutics. However, there remains much debate
in the field regarding the specifics of how and where R-loops are formed, and how they are implicated in gene
regulation in both normal and disease states. This is largely due to a lack of reliable approaches for mapping the
genomic distribution of R-loops in vivo. While multiple approaches exist, many utilize an affinity purification
strategy with an unreliable antibody (S9.6), requiring high inputs and generating noisy data with off-target
artifacts. As such, to accelerate clinical research on neurodegenerative diseases, there is a strong market need
for a next-generation R-loop mapping assay that is highly sensitive, scalable, and reliable.
Here, EpiCypher is partnering with Dr. Jessica Tyler (Weill Cornell) to develop CUTANA-RH™, a novel
approach for genome-wide profiling of R-loops to accelerate aging and neurodegenerative disease research.
The first major innovation of this proposal is the development of a modular immunotethering strategy for genomic
mapping of R-loops, which is compatible with both CUT&RUN- and CUT&Tag-based workflows. Rather than the
unreliable S9.6 antibody, our approach leverages a catalytically inactive RNase H1 enzyme (RH∆) as a highly
specific detection reagent for the DNA:RNA hybrid component of R-loops. In the CUTANA-RH workflows, cells
or nuclei are incubated with GST-tagged RH∆ followed by an anti-GST antibody. Next, pAG-MNase (or pAG-
Tn5) is added for targeted cleavage and sequencing of cleaved fragments, yielding precise localization of
R-loops genome-wide. The second major innovation of our approach is the development of a designer
nucleosome (dNuc) spike-in control panel including dNucs with RNA:DNA hybrid linkers (RH-dNucs). These will
be utilized to 1) perform technical monitoring for assay optimization and sample quality control, and 2) normalize
data for quantitative comparisons. The gains in throughput, sensitivity, and quantification provided by CUTANA-
RH compared to affinity-based approaches will be highly enabling for basic and clinical research. In Phase I
equivalent studies, we developed a first-generation CUTANA-RH assay and demonstrated its ability to reliably
map R-loops in cultured cells. In Phase II, we will generate RH-dNucs and optimize the CUTANA-RH workflows
(Aim 1). We will then validate our assays in a stimulation model and optimize protocols for primary cells and
diverse tissues (Aim 2). We will prepare for commercialization by scaling manufacturing, validating CUTANA-RH
beta-kits, and developing automated workflows to support services (Aim 3). Finally, we will demonstrate the
power of this assay for clinical applications by profiling R-loops in Alzheimer’s disease brain tissue (Aim 3).

Public health relevance
PROJECT NARRATIVE Persistence of stable R-loops is strongly associated with genome instability, aging, and neurodegenerative disorders. Genome-wide profiling of R-loops may unlock new insights into aging and related disease mechanisms (and biomarkers for same), however existing approaches are insufficient for this work. Here, EpiCypher is developing a novel modular approach for genome-wide R-loop profiling that is sensitive, reliable, quantitative, and high-throughput to enable the next generation of aging and neurodegenerative disease research.